Mouse Phenotyping Informatics Infrastructure - MP12

Project summary The Knockout Mouse Phenotyping Project (KOMP) is a critical resource for biomedical research that provides unbiased gene to phenotype associations from genes with little or no-known function, supplying strains for follow-up mechanistic studies and integration across resources to provide new systematic insights into the underlying causes of rare and common disease. The MPI2 Consortium will continue to support KOMP2 and IMPC partners by providing data acquisition, analysis, visualisation, quality control and integration of this valuable dataset. Specifically The MPI2 partners will enhance the Mouse Phenotype portal improving the site layout and navigation for users and making improvements to gene, disease, publication, expression data pages making data more quickly accessible. We will containerise of the infrastructure underlying the web portal. these changes will ease deployment and therefore community re-use of the portal.

Public health relevance
Project narrative Research into the lab mouse provides a unique opportunity to dissect gene function underlying human rare and common disease This project provides access to billions of data points which are consistently analysed and integrated with human health data and data from other models, including cell lines and other species.